VISIBLE KOREAN HUMAN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Keywords: Volume data analysis, visualization and distribution collaboration Abstract: We have obtained the complete optical Visible Korean Human (VKH). This is a full body that has been imaged at 200 micron isotropic resolution resulting in 8704 slices with the total volumetric dataset being 86 GBytes. The dataset also includes some alpha segmented masks for a number of major organs. We have obtained permission to provide public access to this dataset. In the future, we expect to obtain the CT and MRI data for the VKH, plus the female when completed. Once we have successfully served their data, we hope to continue the development of tools for working with these large to very large datasets.